Developmental mechanisms that buffer mutational load in plants

Project Summary
Multicellular organisms face constant mutational pressures due to DNA damage and errors in cell
division. New mutations continually accumulate throughout development and can result in cancer,
aging, and infertility. With the increased sensitivity to detect mutations by deep sequencing, it has
become clear that even healthy individuals are genetically heterogeneous and carry numerous post-
zygotic mutations in both their somatic and germinal cells. This proposal aims to understand how
organisms cope with ongoing mutation during development, focusing on maize and Arabidopsis. First,
we will investigate the accumulation of mutations in different tissues throughout the life cycle. To follow
new mutations, we focus on transposons as it is possible to quantify rare, recent mutations with high
sensitivity. We hypothesize that development is organized in a way that maintains the diversity of the
meristem stem cell niche, avoiding population bottlenecks in critical reservoir cells and thus preventing
any single somatic mutation from reaching fixation across the organism. We will test whether plants
with altered growth patterns and meristem defects accumulate new mutations more frequently
because they are unable to maintain stem cell diversity. Second, we will investigate chromosomal
regulation in the soma and germline during maize pollen development. Each grain of pollen is a simple
3-celled organism, with a single somatic cell and two germ cells. We will study the activation of the
haploid pollen genome and then determine how epigenetic marks that differentiate soma and germline
are established and maintained. Genome changes will be followed using single-cell RNA-seq,
chromatin profiling, and microscopy. We will identify genes that regulate this process using a novel
strategy to perform genetic screens directly in haploid pollen, allowing millions of mutations to be
assayed per plant. Ultimately, this work will shed insight into how organisms regulate multicellular
development and chromosomal structure to reduce the impact of new mutations.

Public health relevance
Project Narrative Mutations that accumulate throughout the life cycle can result in cancer, infertility, and aging. This proposal will characterize how multicellular organisms control genome structure and development in order to reduce the impact of new mutations, focusing on plant transposons because it is possible to follow the spread of transposon-mediated mutations soon after they arise. The goal is to establish general principles that limit the persistence of mutations in diverse species, including humans.